HLS-Rugged point-of-care device for global hemostasis testing of whole blood

DESCRIPTION (provided by applicant): Rheomics is developing a global hemostasis test that uses whole blood. It will enable faster diagnosis and goal-directed therapy of coagulopathies associated with trauma. It will reduce morbidity, mortality, and costs associated with blood product therapy. Our device measures clotting time, kinetics, stiffness, and lysis. Unlike existing devices, ours will use an inexpensive, disposable microfluidic test strip and a robust, easy-to-use analyzer. Our goal is to improve care for the many patients-as many as 6.2 million, just in the US-who develop a coagulation dysfunction that triples their chance of dying. At the same time, we can save hundreds of dollars per patient and hundreds of thousands of dollars for hospital systems.

Public health relevance
PUBLIC HEALTH RELEVANCE: Rheomics is developing a global hemostasis test that uses whole blood. It will improve care for more than 6 million patients who develop trauma-induced coagulopathy and reduce spending on blood product, saving hundreds of dollars per patient and hundreds of thousands of dollars for hospital systems.